Core Grant for Vision Research-Flow Cytometry Core

Flow Cytometry Project Summary/Abstract
The primary purpose of the Flow Cytometry Module is to provide Principal Investigators with a centralized
service for cell counting, fluorescent-activated cell sorting (FACS) to obtain s t e r i l e viable populations of
cells according to specific cellular markers, phenotypic characterization of cells, and biomarker detection.
Such a service makes expensive equipment for FACS sorting and analysis available to researchers. In
addition, the module provides full-time technical support for the maintenance and calibration of the equipment,
helps develop experimental procedures, assists with analysis and interpretation of data, and centralized
internet access to the database.